Types of green spaces and the development of anxiety, depression, and ADHD in rural, low-income communities

Project Summary/Abstract
The mental health of children in the United States is a national emergency, with notable and accelerating rates
of anxiety, depression, and ADHD. Recent research suggests exposure to natural environments (green spaces)
reduces risk for these disorders, alleviating stress, restoring emotional and physiologic resources, providing
opportunities to build regulatory skills through risky play and physical activity, and reducing harm from
environmental stressors, such as heat. The benefits of green spaces may be even greater in low-income areas,
buffering or mitigating the impact of physical and social stressors, and serving to reduce mental health
disparities. Green spaces offer the potential for novel, community-level support to offset risk for anxiety,
depression, and ADHD, yet evidence-based guidelines on the timing and types of exposures that are beneficial
are unclear, as well as the benefits of green spaces for children outside of urban areas. The paradox of high
greenness but poor mental health in rural, low-income communities highlights the need to determine the
factors that alter the relative impact of green spaces. The current proposal seeks to address these gaps,
establishing 1.) the buffering role of green spaces on anxiety, depression, and ADHD risk in low-income, rural
communities, 2) whether the relative benefits of green spaces are consistent across childhood, 3.) whether
different types of green spaces (general vegetation density, proximity to public parks or residential exposure to
woodlands, grasslands, or croplands) convey similar benefits, and 4.) whether green spaces buffer children
from poverty-related adversity in these communities. Drawing from 18 years of observational, survey, and
medical record data gathered from The Family Life Project, a population-based study of 1,292 children born in
low-income, rural communities, the proposed project will derive new, remotely-sensed, geospatial measures of
types of greenspaces around children’s residences, and integrate these measures with extensive child, family,
and home data from 2 months to 16-18 years of age to address critical questions about the types and timing of
green space exposures that offset risk for anxiety, depression, and ADHD. Findings could inform national
policies and feasible interventions to protect and promote green space exposures in ways that maximize
benefits for population-level mental health, and direct future research on the mechanisms through which
exposure to nature offsets future mental health risk.

Public health relevance
Narrative The project will contribute to public health by addressing urgent, fundamental questions about the role of natural areas (i.e., green spaces) in offsetting risk for the development of highly prevalent and pernicious disorders emerging in childhood: anxiety, depression, and ADHD. Determining the timing and types of green space exposures that reduce childhood mental health risk could inform national policies and novel, feasible interventions to protect and promote population level mental health for children and adolescents, and direct innovative future research on the mechanisms through which natural areas offset mental health risk. Further, extending this research into low-income, rural communities will inform potential cost-effective strategies that preserve existing resources, build on community strengths, and reduce mental health disparities.